Annual Conference: American Society of Preventive Oncology

DESCRIPTION (provided by applicant): The primary purposes of the American Society of Preventive Oncology (ASPO) are the exchange of information and the promotion of research in cancer prevention and control. This application requests partial support for the 2009 annual meeting of this small multidisciplinary organization. The 2009 meeting is planned to support interaction between scientists and clinicians of all disciplines concerned with cancer prevention. In order for ASPO to provide a high quality program and to continue to grow and provide new opportunities for junior investigators, some level of outside support is necessary. In recognition of ASPO's limited resources and increasing costs for annual meetings, no honoraria are offered, but expenses of invited speakers are covered. ASPO annual meetings are organized to consist of symposia, submitted paper presentations, award lectures, special interest group breakfast sessions, and a poster session scheduled over two days. Symposia in 2009 will focus on health disparities, cancer survivorship, and the future of cancer control along with several other topics of broad interest to ASPO meeting attendees. Pre-meeting workshops consist of a new investigators workshop, a professional development session, a meeting of the cancer center Associate Directors for Cancer Control and Prevention, and a meeting of NIH trainees. Breakfasts will be reserved for late-breaking topics of interest to the ASPO membership. Several months prior the annual meeting, abstracts will be solicited for oral and poster presentation. The 16 abstracts receiving the highest rankings will be published in the peer-reviewed journal, Cancer Epidemiology, Biomarkers &Prevention. The 18 top-ranked abstracts in various categories will be presented orally during paper sessions. Based on past experience, it is anticipated that approximately 90- 100 posters will be presented during the poster session. An award will be given for the best poster. Journal advertisements, posters and direct mail will be used to publicize the meeting. The 2009 meeting will be in Tampa, Florida, March 8-10, 2009 at the Renaissance Tampa Hotel. (The Renaissance Tampa Hotel is a non-smoking fully-accessible conference facility.) Based on previous meetings, over 300 participants are anticipated to attend. Speakers and participants are from diverse disciplines involved in cancer prevention research, and most significantly from disciplines concerned with translating known information into effective prevention programs. Public Health Relevance: This application is for partial support for the 33rd annual scientific meeting of the American Society of Preventive Oncology (ASPO) in Tampa, Florida, March 8-10, 2009. The goals of ASPO and its meetings are to promote information exchange, stimulate research, and foster programs relevant to cancer prevention and control. ASPO's annual meetings support the health of the public through its unique multidisciplinary emphases on cancer prevention and control research and junior member career development, the high quality and influence of its scientific meetings, and the importance of cancer prevention and control research to the national effort to reduce the burden of cancer.

Public health relevance
This application is for partial support for the 33rd annual scientific meeting of the American Society of Preventive Oncology (ASPO) in Tampa, Florida, March 8-10, 2009. The goals of ASPO and its meetings are to promote information exchange, stimulate research, and foster programs relevant to cancer prevention and control. ASPO's annual meetings support the health of the public through its unique multidisciplinary emphases on cancer prevention and control research and junior member career development, the high quality and influence of its scientific meetings, and the importance of cancer prevention and control research to the national effort to reduce the burden of cancer.